Mitochondrial matrix-localized MCL-1 regulates hematopoietic stem cell self-renewal and regeneration

PROJECT SUMMARY/ABSTRACT
The regulation of self-renewal and multi-lineage differentiation of hematopoietic stem cells (HSCs) is
essential for lifelong maintenance of hematopoiesis, especially under conditions of hematopoietic stress or
transplantation. Defects in HSC repopulating activity contribute to immune deficiencies, anemia, and an
increased susceptibility to myeloid malignancies. HSCs typically exist in a quiescent state, but to self-renew
they must enter the cell cycle. This is associated with an activation of mitochondrial oxidative metabolism.
Thus, understanding how HSC quiescence and proliferation are regulated will provide key insights into how
HSC function can be maintained in aging, under conditions of hematopoietic stress, or during transplantation.
We have demonstrated that MCL-1 is an essential mediator of HSC survival in normal hematopoiesis and
during recovery from stress. These functions are associated with MCL-1's pro-survival function on the outer
mitochondrial membrane; however, MCL-1 can also be imported into the mitochondrial matrix where it
regulates mitochondrial metabolism and fission/fusion dynamics. We have generated a mutant mouse that
expresses a truncated MCL-1 protein (MCL-1OMM) which blocks apoptosis, but cannot be imported into the
mitochondrial matrix. When subjected to myeloablative stress, Mcl1OMM mice exhibit defective regeneration and
most animals die. Furthermore, bone marrow cells from the Mcl1OMM mice exhibit a profound competitive
disadvantage in transplantation experiments.
Our central hypothesis is that matrix-localized MCL-1 regulates mitochondrial dynamics and respiration in
HSCs promoting their ability to self-renew and promote recovery from stress. The following aims will test this
hypothesis: Aim 1: Analyze the HSC phenotype/function from mice lacking mitochondrial matrix-MCL-1. Aim 2:
Determine how lack of mitochondrial matrix-MCL-1 affects mitochondrial dynamics and oxidative
phosphorylation. Aim 3: Interrogate whether enforced expression of matrix-MCL-1 promotes HSC function.
My laboratory has made many seminal findings defining the role of MCL-1 in promoting survival during
normal hematopoiesis and in leukemia. We are uniquely positioned to successfully perform these studies as
we have generated critical, novel model systems that will allow us to functionally dissect MCL-1's functions at
the mitochondria. At the end of this study, we will illuminate a previously unrecognized role for MCL-1 in
regulating HSC function.

Public health relevance
RELEVANCE The proper regulation of self-renewal and multi-lineage differentiation of hematopoietic stem cells (HSCs) is essential for lifelong maintenance of hematopoiesis, especially under conditions of hematopoietic stress and for transplantation. This proposal is relevant to the goals of the National Institutes of Health because it will identify mechanistically how HSC self-renewal and regeneration are controlled by MCL-1. This research will provide insight into HSC exhaustion and supporting transplantation therapies.